Engineering model-based systems to monitor and steer subclonal dynamics

ABSTRACT
Primary tumors as well as cancer cell lines have been shown to exhibit extensive genetic and transcriptional
heterogeneity, with multiple subclones co-existing in the same cancer population.1 Even after decades of in-vitro
growth, established cell cultures continue to evolve.2 The heterogeneity of cancer cell lines over space and time
crystallizes into three unmet needs: i) cell culture protocols that offer a high temporal resolution on in-vitro growth
dynamics; ii) close monitoring of the temporal separation between genotypic and phenotypic measurements and
iii) reconciling the cost-prohibitive nature of repeated high-throughput multi-omic measurements with ceaseless
changes in subclonal composition. To fill these needs, we propose to engineer how in-vitro and in-silica experiments
interact into a software solution called CLONEID. An SOL database in the backend, a Java core and an
R user interface will come together to form two modules: One will record the pedigree of lineages grown in a
lab and use computer vision to monitor phenotypic changes, such as variable growth rates. The second module
will link subclonal multi-omics profiles from different high throughput assays to each other and to the phenotypes
from the first module. In aim 1 we will develop the first module and use it to demonstrate feasibility of monitoring
phenotypic transitions of cell lines with CLONE ID at high temporal resolution, without any specialized equipment.
Aim 2 will use this data in conjunction with existing single cell sequencing of the same cell lines to develop and
test the second module and use it to identify subclone-specific biomarkers of growth. Together these aims will
pave the way to more complex mathematical models of carcinogenesis, that do not have to rely on the simplifying
assumption that individual driver mutations have equal fitness effects and that individual subclones have a fixed
growth rate. In the future, the framework developed here will serve as foundation to deploy computer vision for
early detection of morphological changes, including adaptation from in-vivo to in-vitro growth and mycoplasma
contamination.

Public health relevance
Publlc health statement By enforcing close collaboration between experimental and computational biologists from early phases of experimental design and data collection, CLONEID will help ameliorate the reproducibility crisis in cancer biology. Our framework represents an early step towards leveraging ongoing in-vitro evolution as an opportunity, not a burden. Because durable success in the clinical setting cannot be achieved without an experimental setting in which our solutions are repeatedly challenged with the adaptive nature of cancer.